Development of highly potent human monoclonal for RSV immunoprophylaxis

PROJECT SUMMARY
Globally, respiratory syncytial virus (RSV) causes over 3 million hospitalizations of neonates/infants. While
there are licensed vaccines in the U.S. for use in elderly populations, they are neither approved nor appropriate
for use in neonates/infants who have immature immune systems. Palivizumab, a prophylactic monoclonal
antibody (mAb) marketed by AstraZeneca and Sobi as Synagis™, has been available since 1998, but due to
high cost and modest efficacy, its use has been restricted to high-risk infants. The recently approved single
dose, long-acting mAb, nirsevimab (previously known as MEDI8897 and marketed as Beyfortus™ by Sanofi),
has improved efficacy compared to palivizumab and was approved for use in all children up to 24 months of
age. However, severe shortages and cost barriers have limited its availability in countries where it is currently
approved (EU, US, Japan, Australia, Canada and China). In October 2023 the CDC issued Health Alert
Network CDCHAN-00499 that recommended limiting the use of nirsevimab to higher risk children in the 2023-
2024 season due to the shortages, resulting in many eligible infants not receiving prophylaxis. In addition,
nirsevimab is not currently available in any low- or middle-income countries (LMICs) and is unavailable in 8/10
of the most populous countries in the world.
Mapp Biopharmaceutical, Inc. is developing a fully human mAb product, MBP002, that like nirsevimab,
can be administered in a single dose per RSV season. Mapp’s objective is to dramatically lower the price and
increase the global availability of RSV immunoprophylaxis. Further, unlike nirsevimab and Merck’s Phase 3
candidate, MK-1654, Mapp’s product is a two mAb cocktail, reducing the risk not only of clinical
development of resistance, but also of a naturally occurring strain evading a single mAb. Indeed, this
method of product failure occurred during a recent Phase 3 trial with Regeneron’s RSV mAb candidate and is
the reason several mAb candidates lost their emergency use authorization for use against COVID-19. While
nirsevimab resistant mutations were rare in a survey of 5675 RSV strains between 2015 and 2021, several
mutations in the nirsevimab binding site have increased since 2020, including the resistant RSV-B variant
K68N present in the U.S. and Australia. The impact of widespread use of nirsevimab on the frequency of
resistant variants is under close post-marketing surveillance due to the potential for selection of escape
mutants. Mapp has screened 70+ RSV clinical strains and found neutralization resistant strains to palivizumab,
nirsevimab (MEDI8897) and Regeneron’s candidate, but no resistant strains to one of the MBP002 mAbs. In
addition, the MBP002 mAbs are dramatically more potent in vitro and in vivo than palivizumab and have
comparable neutralization and in vivo activity to nirsevimab.
The requested SBIR support, together with significant in-kind contributions by Mapp, will allow for the
advancement of MBP002 to IND submission (Investigational New Drug Application) and initiation of a Phase 1
clinical trial.

Public health relevance
PROJECT NARRATIVE Respiratory Syncytial Virus (RSV) infects nearly all children by 2 years of age. In the U.S., RSV is the leading cause of lower respiratory tract disease in young children and a major cause of asthma and wheezing throughout childhood. RSV has a disease burden similar to that of non-pandemic influenza A for elderly (>65 years of age) and high-risk adults (congestive heart failure or chronic pulmonary disease). Our long-term goalis to develop a safe and effective product to prevent RSV disease. In addition to infant populations, use of the product in elderly populations may provide protection in nursing homes and rehabilitation hospitals during the RSV season.